Targeting IMAT-derived Extracellular Matrix Proteins as Mediators of Skeletal Muscle Insulin Resistance

The worldwide prevalence of obesity and type 2 diabetes continue to increase substantially in the United States
and globally. Regional fat distribution and ectopic adipose deposition are paramount when considering obesity-
associated metabolic dysfunction, as we now know that adipose tissue is an important endocrine organ,
secreting a variety of bioactive factors that impact nearby tissues. One such ectopic adipose depot, intermuscular
adipose tissue (IMAT), accumulates within the skeletal muscle compartment, between muscle fibers. While
previous research has shown that IMAT directly relates to insulin resistance and type 2 diabetes, mechanistic
studies aimed at addressing how IMAT is involved in the development of metabolic disease are lacking.
Mounting evidence suggests that extracellular matrix (ECM) protein deposition and remodeling is associated
with insulin resistance in skeletal muscle, and recent studies in our lab indicate that IMAT may secrete a greater
amount of ECM proteins compared to other adipose depots such as visceral adipose tissue (VAT) and
subcutaneous adipose tissue (SAT). However, IMAT-derived ECM components have never been investigated in
relation to skeletal muscle insulin sensitivity. Therefore, the goal of this proposal is to identify novel mechanisms
by which IMAT impacts the development of type 2 diabetes, focusing on the central hypothesis that IMAT
secretes ECM proteins that promote skeletal muscle insulin resistance. The first aim of this proposal will test this
hypothesis by expanding upon preliminary data and evaluating the degree to which IMAT, VAT and SAT
secrete extracellular matrix proteins that relate to insulin sensitivity in humans. Conditioned media using
human IMAT, SAT and VAT tissue biopsies will be generated, and secreted Fibronectin (FN), Collagen VI
(ColVI), Fibrinogen-beta (FGB) and Transforming growth factor beta-1 (TGFB1) will be measured using a
combination of multiplex ELISA and proteomic analyses. The second aim of this proposal will determine the
ability of these specific extracellular matrix proteins to increase skeletal muscle insulin resistance in vitro.
IMAT, SAT, and VAT conditioned media will be administered to differentiated L6 myotube cultures to measure
changes in insulin sensitivity. In addition, the ability of FN, ColVI, FGB, and TGFB1 to individually modulate
insulin sensitivity will be measured by isolated treatment of recombinant proteins as well as administration of
FN, ColVI, FGB and TGFB1-null conditioned media. To summarize, these studies will explore potentially novel
mechanisms regulating skeletal muscle insulin sensitivity, highlighting the essential role of IMAT in the
development of insulin resistance and type 2 diabetes.

Public health relevance
Adipose tissue is an endocrine organ that plays a critical role in the development of insulin resistance and type 2 diabetes, which is major health concern world-wide. Synthesis and secretion profiles vary largely between regionally distinct adipose tissue depots, moderating their impact on near-by tissues. The proposed research will explore a novel mechanism by which intermuscular adipose tissue may influence insulin sensitivity in skeletal muscle and attempt to uncover specific new targets aimed at therapeutic interventions for insulin resistance and type 2 diabetes.